Clinical and genetic studies of hereditary neurological disorders in Mali

Summary
Despite the vast diversity of its populations, genetic studies in Africa have been
limited. African populations, Malians in particular, have a high rate of intra-ethnic and
consanguineous marriage, resulting in increased prevalence of autosomal recessive
diseases. Family-based genetic studies can be limited in developed countries due to
small sib ships. The average fertility rate in Mali is over 6 births per woman, offering
a unique opportunity to find new disease genes or mutations that can then be
studied in other populations.
Neurological disorders present public health challenges globally with total disability-
adjusted life years (DALYs) greater than some infectious diseases. These
challenges are even greater when considering hereditary neurological diseases that
cause premature death, severe disability and loss of productivity, resulting in high
health care costs. Although most are currently untreatable, increasing awareness
and community engagement about hereditary neurological disorders can reduce this
burden.
With previous awards, we have established the molecular defects in several families
and identified variants in novel genes for which functional experiments are still
underway. Through genetic counseling and community engagement session,
patients and families as well as their communities have gained knowledge regarding
the cause of these diseases; lifting in part the psychosocial burden, and orienting
their partner choice. However, several families haven’t received their results due to
covid-19-related issues or incomplete genetic and functional analyses. In addition,
community engagement activities were not completed, especially in areas with high
consanguinity. The creation of rare disease patients’ association is an asset to
accomplish this objective.
Sequencing data analysis in several other families has been inconclusive,
necessitating reanalysis or genotyping of additional family members to come to a
diagnosis.
The infrastructures built with the previous award have created a suitable
environment to perform state-of-art research and train the next generation African
scientists. However, students and fellows haven’t finished their in- or out of country
training due to delays. To keep research current in Africa, there is a need to
complete the training of these next-generation scientists.

Public health relevance
Project narrative This project will identify new clinical and genetic neurological entities that may be studied in other populations. Genetic counseling and community engagement will have more impact in decreasing stigma and perhaps decreasing the rate of consanguineous marriages with the effect of reducing the burden of recessive diseases in the Malian population. The acquired infrastructures will set the stage for training the next generation African scientists, and for scientific productivity and advances to ensure sustainability for future generations.